Trial to Assess Chelation Therapy 2 (TACT2) DCC Competing Renewal

The Trial to Assess Chelation Therapy 2 (TACT2) is an ongoing multicenter US-Canada randomized placebo-
controlled trial that has enrolled 1000 post-MI patients with diabetes and is testing, in a factorial design,
whether 40 intravenous edetate disodium-based infusions or placebo infusions and high-dose oral
multivitamins or oral placebo can significantly reduce recurrent ischemic cardiac events. The study has
completed enrollment and seeks funding for 2.5 additional years to complete follow-up, closeout, analysis, and
presentations/publications. This TACT2 continuation proposal consists of a single application by the Data
Coordinating Center (DCC) at the Duke Clinical Research Institute (DCRI) led by Principal Investigators (PI)
Kevin J. Anstrom PhD and Daniel B. Mark MD, with subcontracts to the Clinical Coordinating Center (CCC) at
Mount Sinai Medical Center in Miami Beach FL (Gervasio A. Lamas MD, PI) and the Toxic Metals and
Biorepository Core Laboratory at the Columbia University Mailman School of Public Health in New York City
(Ana Navas-Acien MD PhD, PI). The DCC, and its subcontracts, will coordinate all post-enrollment activities.
This competitive renewal of TACT2 is required to support completion of follow-up, database lock, analyses of
study hypotheses, reporting, publication, and dissemination of trial results
The combined CCC/DCC Specific Aims of TACT2 for this competitive renewal are to:
a. Determine if the chelation-based strategy in patients with diabetes and prior MI improves the
primary composite endpoint of event-free survival;
b. Determine if the chelation-based strategy in patients with diabetes and prior MI reduces all-
cause mortality;
c. Perform an economic analysis of the TACT2 chelation strategy;
d. Determine whether the metal chelation regimen reduces body metal burden in the active
treatment group, and to determine whether treatment effect size is larger among those with
larger metal burden;
e. Assess the effect of OMVM vs. placebo on clinical outcomes;
f. Maintain a biorepository including DNA for future scientific questions.
TACT2, if positive, will not only result in the acceptance of chelation into clinical practice and clinical guidelines
but also will provide important novel insights into the pathobiology and etiology of coronary artery disease.

Public health relevance
Project Narrative (3 sentences) We seek funding to complete the Trial to Assess Chelation Therapy 2 (TACT2), an ongoing multicenter US- Canada randomized controlled factorial trial in 1000 post-MI patients with diabetes, testing whether 40 intravenous edetate disodium-based infusions or placebo infusions and high-dose oral multivitamins or oral placebo reduce recurrent ischemic cardiac events. There is a biorepository for urine and blood. The study has completed enrollment and seeks funding for 2.5 additional years to complete infusions, follow-up, and closeout.